Microfluidics Array Based Sorting, Isolation, and RNA Analysis in Single Extracellular V csicles

Abstract
Extracellular vesicles (EVs) such as microvesicles and exosomes are small membrane vesicles released by
cells in the body. EVs are present in all biological fluids tested (e.g., blood, urine, cerebral spinal fluid) and
contain various biomolecules including DNAs, RNAs, proteins and metabolites, and have been implicated as
part of the cell-cell communication systems. Despite their importance, the current methods of isolating and
characterizing EVs are technically challenging. The isolation methods usually cumbersome and irreproducible,
and the characterization relies on techniques like Polymerase Chain Reaction (PCR), Next Generation
Sequencing (NGS), and Mass Spectroscopy (MS) which just provide an aggregate of the overall RNA/DNA
and protein content. During the characterization process, EVs are broken down to obtain their internal contents.
Consequently, the molecular information at individual EV is lost. Given the heterogeneity of EVs, it is
imperative to study EV-mediated intercellular signaling processes at the single EV level in order to gain
important insights of their effects on promoting drug resistance, immunosuppression, epithelial-to-
mesenchymal transition (EMT), cancer metastasis, and cachexia. Therefore, there is a critical need to develop
technologies that provide accurate and efficient analysis of the molecular content within individual EVs. We
propose an integrated system using a size exclusion chromatography to first sort the EVs in biofluids into well-
defined size-based subpopulations, and then distribute each subpopulation into a set of parallel microfluidic
channels where each channel is patterned with a number of microdomains tethered with antibody-conjugated
liposomal nanoparticles containing molecular beacons (MBs) for enriched isolating/capturing of specific
membrane protein/peptide-rich single EVs in the subpopulation, and simultaneously identification of specific
RNA targets via MB-RNA hybridization when the captured EVs are fused with liposomes. Fluorescence-
labelled antibodies may also be added to each microchannel to quantify the target membrane protein content
of the captured single EVs.
The development and feasibility demonstration of this novel technology will be conducted in the UG3 phase
with a small-scale array for selected RNA and protein targets using well-characterized synthetic vesicles (SVs),
EVs released from glioblastoma (GBM) cell lines, and spiked EVs in normal donor serum. In the UH3 phase,
we plan to scale-up the biochip system design for high-throughput using the GMP type biochip fabrication. The
applicability of this new technology will be validated for EVs from GBM cell lines as well as serum and cerebral
spinal fluid (CSF) from GBM patients. In both phases, EV-based cell-cell communication will be investigated to
determine if and how specific GBM EV subpopulations are involved in immune-regulation within GBMs.
We have assembled a multi-disciplinary team with extensive knowledge and experience in nanobiotechnology,
microfluidics, EV characterization, micro/nano-fabrication, EV RNA profiling and biomarker discovery, GBM
diagnosis and treatment, and biostatistical analysis. The proposed aims and milestones are given as follows:
UG3 Phase- Specific Aim 1: Development of a biochip to capture and characterize specific EV
subpopulations at single EV level. Specific Aim 2: Comparison of results between the single EV-based
measurements and conventional total EV-based averaged measurements. Quantitative Milestones: (i)
Sorting, isolation and quantitative analysis of selected mRNA and miRNA targets in single SVs and EVs with
>90% repeatability and better EV enrichment than conventional ultracentrifugation and antibody-based
microfluidics methods; (ii) Identifying one or more EV subpopulations for high sensitivity detection of GBM cell-
derived EVs; (iii) Identifying one or more GBM EV subpopulations which may involve in immuno-regulation.
UH3 Phase- Specific Aim 1: Scaleup of the biochip manufacturing. Specific Aim 2: To perform EV
analysis on clinical samples from GBM patients. Quantitative Milestones: (i) Sorting, isolation and
quantitative analysis of mRNA/miRNA and membrane protein targets in single EVs from both blood and CSF
samples with >90% repeatability and 5-fold better EV enrichment than conventional ultracentrifugation and
antibody-based microfluidics methods; (ii) <10% false positive/negative prediction from a total of 120 GBM
patients and non-patient samples; (iii) Identifying one or more GBM EV subpopulations which may involve in
immunosuppression and/or associated with worse clinical outcomes.

Public health relevance
PROJECT NARRATIVE In this project, we propose an integrated microchannel-microdomain array-based microfluidic biochip system to isolate, capture and analyze target RNA/protein content at single EV level for human cell lines, biofluids and tissue samples. The applicability of this new technology will be validated for EVs from glioblastoma (GBM) cell lines as well as serum and cerebral spinal fluid (CSF) from GBM patients. Furthermore, EV-based cell-cell communication will be conducted to investigate how specific GBM EV subpopulations are involved in immune- regulation within GBMs.